Epigenetics Core

Project Summary/Abstract
The goal of the Epigenetics core is to provide a robust platform for the identification of genes and their epigenetic
regulation that are altered in distinct brain regions of male and female rats during withdrawal after chronic ethanol
exposure. During the current award period, the Epigenetics Core identified a large number of genes altered in
multiple brain regions during withdrawal and obtained information relevant to local changes in chromatin
architecture. These studies were carried out on bulk tissue dissected from the amygdala, hippocampus, ventral
tegmental area, and medial prefrontal cortex of male and female rats. Moreover, similar, translational studies
were carried out defining the differentially expressed genes and the chromatin domains present in the prefrontal
cortex (BA10) of alcohol use disorder (AUD) subjects as compared with age- and sex-matched control PFC.
While the studies performed in bulk tissues were informative regarding key genes and pathways associated with
ethanol withdrawal, little information was obtained regarding changes occurring in individual cell types in these
specific brain regions.
In the current submission, the proposed aims will complement the studies outlined above by analyzing the
RNA- and ATAC-seq profiles obtained from single nuclei from the central amygdala, dorsal hippocampus, ventral
tegmental area, and medial prefrontal cortex using 10x Genomics (Aim 1). The proposed single nuclei
sequencing strategy will provide information relevant to changes in gene expression and chromatin accessibility
in identified cell types in each brain region. We will prepare and sequence libraries from both male and female
control rats and rats exposed to chronic ethanol followed by a 24 h withdrawal (6 replicates per sex per group
per brain region). These data will also provide novel information regarding which cell types in each brain region
are most responsive to the consequences of withdrawal from chronic ethanol administration. All sequences will
be mapped to the genome and differential expression as well as differential chromatin accessibility will be
determined. All information will be reported to Project PIs as it becomes available. The Core will use a spatial
transcriptomics approach to validate cellular localization of key genes of interest in each brain region (Aim 2).
We will provide epigenetic editing tools to Project PIs to allow for sequence-specific alterations in epigenetic
marks which will be designed to manipulate the expression of specific genes and behavioral phenotypes (Aim
3). In addition, the Core will perform scanning electron microscopy (Aim 4) to image various synaptic features
including dendritic spines, synaptic vesicles, excitatory synapses, etc.to analyze changes in these features in
response to withdrawal from chronic ethanol. Collectively, these data will provide each CARE project with novel
information regarding changes in gene expression and chromatin accessibility in response to withdrawal from
chronic ethanol and the requisite tools to further explore these changes mechanistically.

Public health relevance
Project Narrative The Epigenetics Core will use state-of-the-art technology to obtain genome-wide information at the cellular level that will provide additional resources for each CARE research project to promote research in transcriptomic and epigenomic changes during withdrawal. The tools developed by the Core will help in establishing brain mechanisms causing pathophysiology underlying alcohol use disorder.